AAFCO Animal Feed Regulatory Program Standards Meeting

Project Summary/Abstract
AFRPS Face-to-Face
PAR-19-306 Application
In 2011, Food and Drug Administration (FDA) and AAFCO entered into a partnership to
develop the AFRPS and the AFRPS were initially launched in January 2014. These standards are
designed to promote uniformity and consistency among animal feed regulatory programs and are
consistent with the principles of the FSMA.
Twenty-three (23) states have elected to implement the AFRPS, and fourteen (14) states are
fully implemented. The Cooperative Agreement requires each of these 23 states are required to
attend an annual meeting known as the AFRPS Face-to-Face.
The meeting allows for both groups to gather together and share best practices and any lessons
learned as well as the opportunity to address any concerns that have been identified and discuss
possible solutions to overcome any challenges. Many FDA personnel from varying Divisions
and Offices are present during the Face-to-Face meeting to provide helpful insight andguidance.
In 2022 the Face-to-Face will be held March 15th through noon on March 17th at the Hotel
Ballast in Wilmington, North Carolina. The 2022 agenda capitalizes on the implemented work
in order to assist those States that are in need of guidance to achieve implementation or
accreditation.
The multiple year funding received from the grant will be utilized to further enhance the
collaborative efforts of all those States Programs which are currently enrolled in the AFRPS and
the State Laboratories that are working to achieve ISO 17025:2005 Accreditation. In addition,
funding may be utilized to support travel for personnel from those States which wish to
voluntarily implement the AFRPS to attend the meeting as well.

Public health relevance
AAFCO AFRPS 2022 – 27 Grant Application Project Narrative Form October 7, 2021 Project Narrative The Association of American Feed Control Officials (AAFCO) will utilize grant funding to collaborate with the Food and Drug Administration Office of Partnerships (DIS) and those states that have elected to implement the Animal Feed Regulatory Program Standards (AFRPS) to organize the annual Face-to-Face meeting.